Host-microbe interactions and SARS-CoV-2 susceptibility and symptoms in a novel human challenge model

ABSTRACT
SARS-CoV-2, the etiological agent of COVID-19, has been responsible for more than 600 million reported
infections and 6.5 million deaths globally. Although several antivirals, monoclonal antibodies, and
immunomodulatory treatments improve patient outcomes, mortality from COVID-19 remains unacceptably high.
Moreover, despite mitigation measures and development of several highly effective vaccines, SARS-CoV-2 has
continued to spread globally, making it almost certain that the virus will become endemic in human populations.
There is therefore a critical need to identify host factors that modify SARS-CoV-2 susceptibility and severity to
guide infection prevention strategies and inform future vaccine and therapeutic development studies. SARS-
CoV-2 human challenge experiments provide an unprecedented opportunity to study these host factors by
standardizing the viral inoculum, the precise timing of viral exposure, and environmental conditions, thereby
controlling for factors that inevitably confound natural infection studies. The overall objective of this proposal is
to identify upper respiratory microbiome features and host gene expression profiles that modify susceptibility to
and symptoms of SARS-CoV-2 infection. This research will leverage previously collected clinical data and
samples from a first-in-human SARS-CoV-2 challenge study conducted in healthy adults without serological
evidence of prior infection or vaccination. We will perform shotgun metagenomic and RNA sequencing of serially
collected mid-turbinate nasal samples from 34 adults who were inoculated with a wild-type virus (SARS-CoV-
2/human/GBR/484861/2020), 18 (53%) of whom developed PCR-confirmed infection. In Aim 1, we will use nasal
samples collected at baseline and immediately following viral inoculation (days -1 to +3) to identify microbiome
features and host transcriptional responses associated with resistance to SARS-CoV-2 infection. In Aim 2, we
will use nasal samples collected between days -1 and +14 to characterize changes in the upper respiratory
microbiome and host transcriptome that occur during SARS-CoV-2 infection and correlate microbiome and
transcriptome profiles with the presence and severity of specific symptoms of SARS-CoV-2 infection. In both
Aims, we will use innovative multi-omics analyses to identify relationships between patient characteristics, upper
respiratory microbiome-transcriptome profiles, and SARS-CoV-2 susceptibility and symptoms. This research will
identify upper respiratory bacterial species associated with susceptibility to and symptoms of SARS-CoV-2
infection and could lead to development of rationally designed probiotics that prevent SARS-CoV-2 infection.
Further, a detailed understanding of the host responses that occur in the upper respiratory tract following SARS-
CoV-2 exposure and infection could inform development of nasal vaccines and identify novel targets for host-
directed diagnostics or therapeutics. Finally, analyses integrating microbiome and host transcriptome data will
elucidate mechanisms by which the upper respiratory microbiota and host immune system interact to influence
susceptibility to and severity of infections caused by SARS-CoV-2 and other respiratory viruses.

Public health relevance
PROJECT NARRATIVE SARS-CoV-2, the virus that causes COVID-19, continues to cause widespread infections associated with unacceptably high mortality. We will use previously collected samples from healthy volunteers inoculated with SARS-CoV-2 in a human challenge study to identify microbes and host immune responses in the upper respiratory tract that modify susceptibility to and symptoms of SARS-CoV-2 infection. These analyses could lead to development of new vaccines or therapies to prevent or treat SARS-CoV-2 infection.